Shared Resource 04: Clinical-Translational Science (CTSSR)

PROJECT SUMMARY – CLINICAL-TRANSLATIONAL SCIENCE SHARED RESOURCE (CTSSR)
The goal of the CTSSR is to foster the clinical-translational mission of OSUCCC members without wet-
laboratories by providing support and short-term needs for correlative science and other testable hypotheses.
The CTSSR is a consultative project management and central laboratory service that was developed with a
focus on investigator-initiated solid tumor clinical trials, but now supports all types of dry laboratory researchers
(hematological malignancy and population scientists). During the current funding cycle, the CTSSR, formerly
known as the Solid Tumor Translational developing Shared Resource (SR) was funded through CCSG
development funds, and is now being proposed as a full CCSG SR. The Specific Aims of the CTSSR are to: 1)
provide project design and project management support (including navigation, protocol development, grant
application and manuscript preparation) for studies that utilize resources available through other OSUCCC SRs,
investigator laboratories, and outside vendors; 2) provide specific laboratory services and sample processing
support for clinical translational research; and, 3) develop and rigorously perform customized laboratory assays
to meet the short-term needs of clinical investigators for a specific protocol, a specified time, or a specified
number of patient samples. Conveniently located within the Biomedical Research Tower, the CTSSR is
accessible to most OSUCCC clinicians and tissue procurement services. Major equipment includes a cell culture
facility, a QX200 Droplet Digital PCR System-Bio Rad and a Promega Maxwell RSC for high throughput nucleic
acid purification, and a Luminex Magpix for multiplex protein assays. During the current grant period, the CTSSR
has supported 94 investigators (62% OSUCCC members), and provided 8,223 hours of service and processed
3,602 samples (82.9% to OSUCCC members). The CTSSR provided services in support of 72 publications (14
> 10 impact factor), 94 users, and 9 NCI grants, including 1 K01, 2 P01s, 1 P50, 4 R01s, and 1 R03. The CTSSR
currently supports 20 ongoing trials and there are 8 new ones in the pipeline (spanning all five programs). It is
anticipated that the CTSSR will expand rapidly due to the continued rapid growth of the OSUCCC with its
strategic priorities. Specific future plans include participating in the developing Immune Monitoring and Discovery
Platform, fostering interactions with other shared resources for immuno-oncology projects; increase support for
hematologic and population science studies; establish a cell culture facility to enable preclinical cancer cell
culture studies (including drug synergy) needed as pilot data for human studies applications; and provide
multiplex protein arrays for human studies using whole cells, cell/tumor extracts and other biological fluids. The
annual budget of the CTSSR is $552,510, yet the CCSG request is $60,723. As such, The CTSSR leverages
extensive institutional support and seeks only 11% support from CCSG funds.